Mechanisms of adverse gastrointestinal events during oral immunotherapy

ABSTRACT
This K23 award application requests support for the career development of Dr. Benjamin Wright, Assistant
Professor in the Division of Allergy, Asthma and Clinical Immunology at Mayo Clinic Arizona. The candidate’s
overall goal is to become an independent, clinician-investigator and improve the health of individuals with
eosinophilic esophagitis (EoE) and food allergy through patient-oriented research. This award will provide the
training and support needed to accomplish this goal. Specifically, this proposal will enable Dr. Wright to
accomplish the following short-term career goals: (1) acquire training in methods and design of clinical studies
and trials in food allergy; (2) develop skills in basic/translational research techniques; (3) develop professional
skills necessary to lead a translational research team; and (4) gather preliminary data and biospecimens for a
subsequent R01 application and establish an independent research program in food allergy and eosinophilic
gastrointestinal disorders. Oral immunotherapy (OIT) is an emerging treatment for food allergy. Although most
patients can be successfully desensitized with OIT, many develop gastrointestinal side effects including EoE.
EoE is a chronic allergic condition associated with severe esophageal dysfunction. The specific goals of the
research proposal are to examine the mechanisms underlying the gastrointestinal side effects of OIT and to
develop a novel treatment strategy to prevent them. To accomplish this, we will perform a sub-study of a
placebo-controlled trial in patients with milk allergy treated with milk OIT with or without dupilumab. During the
trial, we will serially monitor eosinophilic inflammation, markers of esophageal barrier dysfunction, and immune
responses in peripheral blood and in the esophagus. To support Dr. Wright’s career development, he will
acquire skills in cellular immunology and complete a basic science internship focusing on cutting-edge
proteomic analysis of clinical samples. In addition, he will complete formal didactic coursework in clinical
research study design, biostatistics, and bioethics. Dr. Wright has assembled a mentoring committee
comprised of international experts in food allergy, EoE, proteomics, eosinophil biology, and type 2 immunity
uniquely suited to address the hypotheses set forth in this proposal and guide Dr. Wright’s career
development. This proposal combines the strength of the research environment at Mayo Clinic and an ongoing
collaboration with Stanford University that provides an ideal setting to pursue the aforementioned training and
research goals. At the conclusion of this program, Dr. Wright will have the skillset and experience required to
transition to independence and lead a translational research team. Successful completion of this project will
likely provide a major and sustained impact on the care of patients with food allergy by providing critical
insights into the pathogenesis of food allergy and EoE.

Public health relevance
PROJECT NARRATIVE Oral immunotherapy (OIT) is a promising treatment for food allergy; however, it may cause gastrointestinal side effects including eosinophilic esophagitis (EoE). The overall goal of the proposed research is to understand the mechanisms underlying the gastrointestinal side effects of OIT. We will pursue this goal by studying eosinophil and other immune responses in the blood and the esophagus during a clinical trial of dupilumab with milk OIT, which may help us improve treatments for food allergy and better understand the pathogenesis of EoE.